Learning to see again: biological constraints on cortical plasticity and the implications for sight restoration technologies

ABSTRACT
The field of sight restoration has made dramatic progress: within a decade, many blind
individuals are likely to be offered a wide range of options for sight restoration that depend on
widely different technologies, including retinal implants, cortical implants and optogenetics.
However, interactions between implant electronics and the underlying neurophysiology of the
retina or cortex mean that the vision provided by most of these technologies will differ
substantially from normal sight.
What role does cortical plasticity play in helping patients make use of this artificial visual
input? Over the past 15 years our research group has been generating computational models,
developed using a combination of physiological and psychophysical data, which predict the
percepts that patients might experience for a variety of sight recovery technologies. We propose
to use these models to simulate, within visually normal participants, a critical
neurophysiological distortion inherent in many sight restoration technologies: the simultaneous
stimulation of on and off cells.
Our goal is to see how training with this distorted input alters neural representations in object
selective areas such as lateral occipital cortex (LOC). Using fMRI, we will measure neural
responses to distorted and undistorted objects, before and after training with distorted input.
One possibility is that learning to recognize distorted objects results in distorted object images
becoming cues for previously learned neural representations within LOC. The alternative is that
this training results in the generation of novel representations within LOC. This work will
provide novel insights regarding the fundamental mechanisms of cortical plasticity by asking
whether, in adulthood, it is possible to reconfigure the fundamental building blocks of visual
perception?

Public health relevance
Project Narrative Within a decade, many blind individuals are likely to be offered a wide range of options for sight restoration - including electronic prostheses, gene therapy and optogenetics. However the vision provided by almost all of these technologies will differ substantially from normal sight. We will use functional magnetic resonance imaging to examine how training with input that the artificial visual input provided by sight recovery technologies alters neural responses within visual cortex.